Interactions of Enzyme-Inducing Antiepileptic Drugs with Direct-Acting Oral Anticoagulants: Risk of Thromboembolic Events

Project Summary/Abstract
Epilepsy affects over 70 million people worldwide, including an estimated 3.4 million in the US. Multiple widely-
used antiepileptic drugs (AEDs) have off-target effects inducing key drug metabolizing enzymes, yielding
numerous potential drug-drug interactions (DDIs). One such interaction with particularly high real-world
relevance, but minimal clinical evidence, has been purported to occur between these enzyme-inducing AEDs
(EI-AEDs) and direct-acting oral anticoagulants (DOACs). Co-prescription of AEDs with anticoagulants is
common due to the frequent concurrency and causal links between epilepsy and the main indications for DOACs.
EI-AEDs induce two crucial components of DOAC absorption and metabolism, which may lead to lower,
potentially sub-therapeutic, levels of DOACs, and an increased risk of thromboembolic events. Evidence for
these DDIs is composed primarily of in vitro and animal data. Existing human studies have limited real-world
applicability due to both: substantial inconsistencies in findings, and methods that put the research at high risk
for bias and confounding. Further, these human studies’ narrow focus on pairwise EI-AED/DOAC interactions
disregards the potential role of higher-order drug-drug-drug interactions (3DIs), particularly given the high
prevalence of polypharmacy in epilepsy populations. The goal of this research plan is to apply methodologically
rigorous designs and leverage large-scale administrative claims data to address knowledge gaps regarding real-
world DOAC therapeutic failures associated with EI-AED and concomitant drug interactions. In Aim 1, we will
use a retrospective incident user cohort design to compare thromboembolic event rates in adults with epilepsy
exposed to DOACs with EI-AEDs versus an active comparator group exposed to DOACs with non-enzyme
inducing AEDs (NEI-AEDs). Given critical differences in utilization and thrombotic risk, we will separately analyze
DOAC use for atrial fibrillation (1A) and deep vein thrombus/pulmonary embolism (1B). To generate effect
estimates with vigorous control for observed and unobserved confounders (via proxy-adjustment), data-adaptive
high-dimensional propensity scoring will be employed. In Aim 2, we will use a case-crossover design to explore
the role of 3DIs in thromboembolic events in adults with epilepsy prescribed EI-AEDs and DOACs. A novel within-
person approach to 3DI screening will be undertaken based on the temporal associations of concomitant drugs
with thromboembolic events. Estimates will be quantitatively compared to a negative case group prescribed NEI-
AEDs with DOACs in order to mitigate the direct effects and confounding by concomitant drugs, as well as to
differentiate 3DI from DDI signals. Overall, this research will contribute to the advancement of prescribing
standards for epilepsy patients requiring anticoagulation and provide benchmarks for future 3DI investigations.
The valuable skills and experiences gained from this mentor-guided research and training will serve as essential
foundations for the applicant to build continued postdoctoral research initiatives, and to advance towards a career
as an independent investigator-clinician specializing in neuroepidemiology and pharmacoepidemiology.

Public health relevance
Project Narrative Treatment of the frequent indications for anticoagulation among adults with epilepsy is complicated by theoretical pharmacokinetics, as well as in vitro and animal data, that support interactions between widely-used enzyme- inducing antiepileptic drugs (EI-AEDs) and direct-acting oral anticoagulants (DOACs), which would be expected to lead to a reduction in the therapeutic effectiveness of DOACs and an elevated risk of thromboembolic events. However, this may not translate to real-world changes in thromboembolic event risk upon co-prescription of these drugs, and there is scant research on EI-AED/DOAC interactions in humans, with the small number of available studies having highly inconsistent findings, major methodological limitations that impede interpretability, and an overall lack of consideration of the potential role of higher-order drug interactions. Leveraging large-scale administrative claims data to evaluate a nationally representative population of adults with epilepsy in the real- world setting, the proposed research will assess the associations between thromboembolic events and EI-AED/DOAC interactions, as well as the contributions of concomitant medications via three-way drug interactions, in order: to provide vital foundations for prescribing decisions in the substantial proportion of epilepsy patients that require anticoagulation; to report observed three-way drug interactions signals associated with EI-AEDs and DOACs to drive further investigations; and, to advance potential approaches for higher-order drug interaction screenings using real-world data.